Optimizing dietary adherence in a mobile behavioral weight loss intervention for adults

Obesity remains a critical public health concern. Digital web- and mobile-delivered behavioral weight loss
(BWL) interventions with little or no human support are low-cost approaches to adult obesity treatment with 30-
60% of participants achieving 5% weight loss at 6 months. Newer, adaptive intervention approaches have
provided alternative treatments to participants who are struggling (non-responders), but few have been tested
and have universally used early weight change as an indicator of treatment response. This focus on early
weight change obscures the importance of proximal behavioral goals, including the impact of adherence to
prescribed dietary recommendations on weight change, and there remains a gap in understanding what types
of intervention components can directly target and improve dietary adherence. To fill this gap and inform
precision intervention approaches, and in response to NOT-OD-21-100 (NOSI: Improving Patient Adherence to
Treatment and Prevention Regimens to Promote Health), we will use an innovative design that uses a factorial
trial, as part of the Multiphase Optimization Strategy (MOST) framework, to optimize dietary adherence for
non-responders in a mobile BWL intervention. Our team developed a standard mobile-delivered BWL program
(core BWL) that is automated except for a brief kick-off session with staff. The core BWL includes daily calorie
goals and smartphone-based calorie tracking (dietary self-monitoring; DSM). In our pilot trial, participants
identified as non-responders in the first 8 weeks (participants who had 2 consecutive weeks with < 3 days/wk
of DSM and calorie goal adherence; 64% of sample) achieved -2.5% (SD=4.8) weight loss at 6 months
compared to -11.0% (SD=8.0) among responders. Thus, in the proposed trial we will recruit N=580 adults to
participate in the 6-month core BWL program and will use DSM data to continually evaluate and identify
participants who are non-responders (< 3 days/wk DSM and calorie goal adherence in prior 2 weeks) over the
first 8 weeks. At the time participants are identified as non-responders (~ 65% of sample; N=377), they will be
randomized in a factorial trial to receive or not receive each of 4 additional intervention components that
specifically target improved dietary adherence: 1) switching to a simple dietary approach, 2) adding
autonomous goals + planning modules, 3) adding just-in-time (JIT) messages, and 4) adding 3 coach
sessions. Assessments will occur at baseline, 4 weeks (brief), 8 weeks (brief), 3 months, and 6 months to
accomplish the following aims: 1) Determine the combination of additional intervention components that
maximize dietary adherence among non-responders; 2) Conduct mediation analyses to test the relationships
between the additional components and hypothesized mediators (self-regulation, perceived competence,
relevance, supportive accountability); and 3) Conduct moderation analyses to identify for whom the additional
components are most effective and predictors of early response. Our findings will inform the development of an
optimized adaptive intervention that maximizes adherence to prescribed dietary recommendations.

Public health relevance
PROJECT NARRATIVE Mobile behavioral weight loss programs offer unmatched potential for wide reach and impact, but there is high variability in adherence to dietary recommendations and weight loss outcomes. Newer intervention approaches offer the ability to test treatments that “rescue” participants who are struggling. Building on our pilot data, this study aims to identify the optimal treatment strategies for maximizing dietary adherence and overall improved rates of program success.